Uncovering the substrate recognition mechanisms of the E3 ligase adaptor cereblon

PROJECT SUMMARY
The immunomodulatory drugs thalidomide, lenalidomide, and pomalidomide exert their therapeutic effects by
tailoring the substrate specificity of cereblon, a component of the ubiquitin proteasome system, resulting in
altered substrate recruitment, ubiquitylation, and degradation. However, the native substrate specificity and
biological functions of cereblon are elusive, despite the conservation of cereblon across species, its association
with neurological development, and the potential impact that therapeutic engagement of cereblon would have
on these substrates and pathways. To address the urgent need for better characterization of the native role
cereblon plays in biological regulation, we undertook a novel approach to discover the substrate recognition
mechanism of cereblon. We used a targeted protein degradation approach to systematically screen
physiologically relevant ligands for functional engagement of cereblon in cells and discovered that we could
replace thalidomide with peptides bearing a C-terminal glutarimide or aspartimide, which are post-translational
modifications derived from cyclization of glutamine or asparagine, respectively. Endogenously, these C-terminal
cyclic imides may act as molecular glues to recruit substrates to cereblon by tailoring substrate recognition,
analogous to thalidomide, or may be generated directly on the substrate during protein aging and damage
response or in response to signaling events. To address these two hypotheses, we will functionally characterize
the recognition of these C-terminal cyclic imides by cereblon in cells in the context of two models: as peptide-
based metabolites that alter substrate recognition or as part of a novel degron found at the C-terminus of proteins
after protein aging or during a signaling event. We will first fully evaluate the recognition of peptide-based ligands
in the context of bifunctional degraders for targeted protein degradation to characterize the scope and
ligandability of cereblon by peptides and evaluate their ability to act as molecular glues for substrate recruitment
in a manner analogous to thalidomide and lenalidomide. Next, we will assess whether C-terminal cyclic imides
act as degrons that promote substrate recognition directly on engineered and endogenous proteins in biological
systems. To facilitate the study of these modifications, we will develop orthogonal chemical labeling strategies
to detect and map where and when these modifications occur in cells. Finally, we will investigate the formation
of these modifications in cells to characterize the conditions, pathways, and “writers” that generate the C-terminal
cyclic imides recognized by cereblon. The definition of C-terminal glutarimide and aspartimide modifications as
the key recognition elements used to recruit endogenous substrates to cereblon and the associated studies
constitutes a significant advance that will open new investigations into the biological regulation of proteins
through these post-translational modifications and the effects on these pathways during cereblon engagement
by small molecules, which will inform the use and development of therapeutics that engage cereblon in the clinic.

Public health relevance
PROJECT NARRATIVE Cereblon plays a role in selecting protein substrates for degradation as part of the cell’s protein degradation machinery. The substrates that cereblon selects for degradation are tailored by small molecules to promote human health in the clinic, yet how cereblon selects its native substrates and what these substrates are is unknown. Here we will use chemical approaches developed in our lab to illuminate cereblon’s substrate selection mechanism via a novel post-translational modification for identification of these substrates and their biological pathways.